Administrative Core

PROJECT SUMMARY/ABSTRACT – Administrative Core
The purpose of the Administrative Core (Core A) is to support the translational objectives of the UCLA
SPORE in Brain Cancer by serving as its organizational hub. The Core is responsible for the oversight and
daily functions of the SPORE and provides organizational, administrative, and scientific leadership (both
basic and clinical) for all of the aspects of the SPORE, including coordination and communication between all
investigators and committee members. It will provide scientific management, including ongoing oversight and
scientific review of all projects and cores to ensure that the stated scientific goals of the SPORE are met.
The Core has ultimate responsibility for the overall financial management of the budget and appropriate filing
of budgetary information. It will organize regularly scheduled meetings and seminars, and provide
commitment of SPORE investigators to attend the annual NCI Brain SPORE Mid-Winter Retreat and other
relevant NCI-related meetings/workshops and activities. The scheduling and organization of an annual UCLA
Brain Cancer SPORE Symposium, including participation of the External Advisory Board (EAB), will be the
responsibility of the Administrative Core. This Core will oversee the administration of the SPORE
Developmental Research (DRP) and Career Enhancement Programs (CEP), while providing oversight and
assuring compliance with all UCLA, NCI, and Federal regulations and requirements, including maintenance of
appropriate animal and human subject approvals and monitoring of all the established policies for the
inclusion of women and underrepresented minorities. It will be the liaison between the SPORE and the NCI-
designated Jonsson Comprehensive Cancer Center, other UCLA academic and administrative bodies,
NIH/NCI staff, IAB/EAB members, and patient advocacy groups. The Administrative Core will also ensure
that data and resources are shared appropriately in order to promote intra- and inter-SPORE collaboration,
provide integrated and centralized data management support through a new UCLA Brain SPORE Data
Management (Brain-SPOD) platform, and maintain/update the UCLA Brain SPORE intranet and website.
The Administrative Core is led by Linda M. Liau, MD, PhD, MDA, the SPORE principal investigator, who
oversees all UCLA Brain Cancer SPORE activities.